Strategies for Optimizing a Mailed FIT Program in Appalachia

PROJECT SUMMARY
Colorectal cancer (CRC) is the third most common cancer among both men and women and the second
leading cause of cancer deaths in the United States (US). CRC screening is now recommended for average-
risk adults ages 45-75, yet many adults in the US are not within screening guidelines. One recommended CRC
screening approach is annual completion of a fecal immunochemical test (FIT). FIT can be completed at home
and sent/returned via mail, making mailed FIT programs a promising way to reach people and increase CRC
screening. Such programs may be especially important for geographic regions with lower access to healthcare
and lack of public transportation, such as the Appalachian region of the US. Mailed FIT programs have been
shown to increase CRC screening, but typically fewer than half of participants in these programs who were
sent a FIT returned a completed test. This indicates that mailed FIT programs can be greatly improved upon by
addressing common barriers to FIT return. A key next step in this field of research is to identify strategies that
can address these barriers and subsequently increase FIT return in mailed programs.
Our study team will build on our past research and take this key next step. In doing so, we will partner with
health centers in Appalachian counties that are located in a CRC “hotspot” within the US (i.e., clusters of
counties with high CRC rates). The proposed study will involve a mailed FIT program (called “FIT Starts at 45”)
that includes 500 participants from Appalachia who are underscreened and ages 45-74. We will determine the
efficacy and cost-effectiveness of two potential strategies for increasing FIT return: FIT kit materials (enhanced
FIT kit that includes a video brochure vs. standard FIT kit) and patient navigation (PN) delivery mode (text
message PN vs. telephone PN). In a 2x2 between-subjects factorial randomized trial, each participant will be
randomized to one of the following study groups: standard FIT kit plus telephone PN; standard FIT kit plus text
message PN; enhanced FIT kit plus telephone PN; or enhanced FIT kit plus text message PN. The proposed
study will be one of the most innovative and comprehensive mailed FIT programs to date in the US, with each
study aim making a significant research contribution. Aim 1 will determine the efficacy of FIT kit materials and
PN delivery mode on increasing FIT return. FIT return will be defined as return of a completed FIT by
participants within six weeks of FIT distribution. Aim 2 will determine if efficacy differs across key
characteristics of participants and their communities (i.e., moderation). Aim 3 will compare the cost-
effectiveness of FIT kit materials and PN delivery mode on increasing FIT return. Results will be impactful by
providing an evidence base that can help optimize the design, implementation, scalability, and sustainability of
future mailed FIT programs, including our own efforts to disseminate the FIT Starts at 45 program.

Public health relevance
PROJECT NARRATIVE The proposed study will identify multilevel strategies that can help optimize mailed FIT programs. In doing so, it will assess the efficacy and cost-effectiveness of two promising strategies, FIT kit materials and patient navigation delivery mode. Results will provide an evidence base that can guide the design, implementation, scalability, and sustainability of future mailed FIT programs.